A Randomized, placebo-controlled trial of the effects of Long-Acting GLP-1 or Dual Incretin (GLP-1 and GIP) Modulation on Gastrointestinal Functions and Relationship to Weight Loss

ABSTRACT
Obesity prevalence continues to increase in our country and worldwide. The incretins, GIP and GLP-1,
facilitate disposal of ingested nutrients and lead to glucose-dependent insulin secretion or inhibition of
glucagon secretion. Medications targeting these receptors are effective in inducing weight loss;
however, they are frequently associated with gastrointestinal (GI) adverse events (AEs), particularly
nausea, and possibly development of gastroparesis. We previously demonstrated that the daily-administered
GLP-1 receptor agonist (GLP-1RA), liraglutide (3mg SQ), slowed gastric emptying of solids (GES) and induced
mean weight loss of 5.6kg at 16 weeks. Among patients treated with liraglutide, 60% had documented GES
T1/2 >174 minutes (“gastroparesis range”) at 5 weeks and 30% at 16 weeks, suggesting that tachyphylaxis
occurs with continued treatment with the daily-administered GLP-1RA liraglutide. GLP-1RA treatment has been
associated with risk of lung aspiration during endoscopy, suggesting clinically relevant slowing of GES.
The overall hypothesis is that pharmacological incretin-based agents administered weekly, semaglutide
(GLP-1RA) and tirazepatide (dual GLP-1 and GIP receptor agonist), significantly retard GES, but the
effect on GES is heterogeneous, associated with tachyphylaxis, and may persist after cessation of
treatment with these agents. Effects of the weekly administered semaglutide on GES beyond 4 weeks’
treatment is unknown. Tirzepatide administered for 4 weeks delayed GE of liquids; effects on GES are
unknown. GES is more relevant for risk of pulmonary aspiration with these medications. The effects of
semaglutide and tirzepatide on gastric functions (accommodation and emptying of solids) and on GES at 4
weeks after stopping these medications are unknown.
We propose one specific hypothesis and aim in obese/overweight adults eligible for these medications.
Hypothesis: Semaglutide or tirzepatide result in slowing of GES and increased satiation with considerable
inter-individual heterogeneity and evidence of tachyphylaxis.
Specific Aim: To compare effects of weekly SQ semaglutide 2.4mg SQ, SQ tirzepatide 10mg, and placebo
administered for 24 weeks on GES measured repeatedly at baseline, 16 weeks, 24 weeks, 28 weeks, 4 weeks
after stopping the medication, and accommodation and satiation at 24 weeks compared to baseline.
Significance: Our study will document heterogeneity in the effects of semaglutide or tirzepatide on gastric
motor functions and satiation, the potential for tachyphylaxis in the effect on GES or the persistence in slowing
of GES after stopping treatment. This pilot trial will also provide initial data on the coefficient of variation of the
effects on GES and satiation in response to the 2 drugs in order to develop the power statement for future
clinical trial comparison of semaglutide and tirzepatide.

Public health relevance
Project Narrative / Relevance Obesity treatment with medications targeting GLP-1 has been associated with stomach slowing or even paralysis which may lead to food regurgitation causing lung infection. This study will compare to placebo the effects of semaglutide and tirzepatide, approved medications with action on 1 or 2 appetite hormone targets, on stomach functions, particularly emptying, in overweight or obese adult participants with prediabetes or type 2 diabetes. In addition, the study will document whether there are differences between individuals in the slowing of the stomach emptying and whether this corrects itself or persists over time.